DF/HCC Preclinical Translation-Focused Clinical Investigator to Bridge PDXNet and the ETCTN

ABSTRACT
This application is being submitted to request the addition of a Preclinical Translation-Focused Clinical
Investigator (PT-FCI) to the Dana-Farber/Harvard Cancer Center (DF/HCC) ETCTN UM1 Lead Academic
Organization (LAO). Dr. Geoffrey Shapiro will serve as the DF/HCC PT-FCI. He has expertise in preclinical,
translational, and clinical science and is poised to serve as a bridge between PDXNet and the ETCTN. As a PT-
FCI, Dr. Shapiro will engage in three sets of activities. First, he will establish interactions with PDXNet scientists
through attendance at network-wide and Clinical Translation meetings, in which he will provide guidance on
prioritization of models and agents to be used in preclinical studies. Second, he will continue extensive mentoring
of early- and mid-career ETCTN investigators in the development of Letters of Intent (LOIs) and will determine
whether required high-quality preclinical data are available within PDXNet or whether such data can be
developed to support ETCTN LOIs. Finally, he will identify at least one high-priority PDX therapeutic study to be
conducted per year that will provide data to support development of ETCTN clinical trials, including studies
addressing health disparity-related projects. PDX therapeutic studies will be performed in his laboratory, the
Dana-Farber Cancer Institute (DFCI) Experimental Therapeutics Core or in the laboratory of a DF/HCC, Harvard
Medical School or PDXNet collaborator. These activities will collectively contribute to strengthened interactions
between PDXNet and the ETCTN, resulting in rigorous preclinical data that will inform ETCTN clinical trials.

Public health relevance
PROJECT NARRATIVE Dr. Geoffrey Shapiro will serve as the Dana-Farber/Harvard Cancer Center Preclinical Translation-Focused Clinical Investigator (PT-FCI), tasked with creating a translational bridge between PDXNet and the ETCTN. He will engage with PDXNet investigators through interactive meetings in which he will provide consultation on appropriate models and agents for preclinical studies and will provide guidance to ETCTN early- and mid-career investigators on availability of data to strengthen Letters of Intent for early phase studies. He will also oversee the conduct of high priority preclinical therapeutic studies that will inform novel ETCTN trials.